Impact of microRNA processing on EMT of ovarian cancer cells

Project Summary
Accumulating evidences have clearly demonstrated that microRNA (miRNA) system plays an active role in
tumor-associated epithelial-mesenchymal transition (EMT) and tumor progression. Our PubMed-based search
revealed that there are overwhelmingly more miRNAs serving as EMT suppressors than those promoting EMT
in ovarian cancer (23 vs 3), indicating that overall miRNA system play an EMT-suppressive role in ovarian
cancer. This is consistent with our observation that impairing miRNA biogenesis by silencing Drosha and Dicer
induces the occurrence of EMT traits in epithelial-like ovarian cancer cells. Comparing the abundance of EMT-
suppressive miRNAs in ovarian cancer cells, we noticed that levels of EMT-suppressive miRNAs are much
less in mesenchymal-like cell lines than epithelial-like ones. Intriguingly, levels of the respective primary
miRNAs (pri-miRNAs) in majority of these miRNAs are similar between mesenchymal- and epithelial-like
ovarian cancer cells. These results indicate that the biogenesis of miRNA (processing of pri-miRNA to miRNA)
is not efficient in mesenchymal-like ovarian cancer cells. We showed that blockage of miRNA biogenesis
requires the presence of interleukin enhancer-binding factor 3 (ILF3) because knockdown of ILF3 increases
miRNA biogenesis. In an effort to understand how ILF3 inhibits miRNA biogenesis, we found that protein
kinase Cδ (PKCδ), a novel PKC isoform, can phosphorylate ILF3 and that PKCδ is required for the deterrence
of miRNA biogenesis in mesenchymal-like ovarian cancer cells. Based on these findings, we formed our
central hypothesis: PKCδ promotes ovarian cancer EMT and tumor development by conferring ILF3 with
the ability to deter the biogenesis of EMT-suppressive miRNAs. These findings also provide the basis to
develop a novel ovarian cancer-targeted therapeutic modality that is to establish efficient miRNA processing in
ovarian cancer cells through the interference of PKCδ function. Three aims are proposed in this application: 1)
Elucidate the mechanism underlying PKCδ regulation of miRNA processing; 2) Define mechanisms associated
with PKCδ/ILF3 regulation of EMT in ovarian cancer cells; and 3) Investigate the potential of interfering with
PKCδ function to suppress ovary tumorigenesis. The success of this application will help our understanding on
how PKCδ/ILF3 functional axis blocks miRNA biogenesis and also demonstrate the potential of suppressing
ovary tumorigenesis by targeting PKCδ.

Public health relevance
NARRATIVE Epithelial-mesenchymal transition (EMT) is a critical step for ovarian cancer progression and development. This proposal aims to understand the molecular mechanism underlying the poor expression of EMT- suppressive microRNAs in mesenchymal-like cells (aggressive cancer cells). This aim also aims to develop an ovarian cancer-targeted therapeutic strategy by elevating the expression of EMT-suppressive microRNAs.